Biostatistics Core

PROJECT SUMMARY –CORE B
The Biostatistics Core (Core B) will provide comprehensive, centralized biostatistical support for
all four research projects. This support will integrate the biostatistical activities at the University
of Texas MD Anderson Cancer Center (MDACC), Harvard University, and Children's National
Health System (CNHS) at The George Washington University. These activities will include
design of pre-clinical studies and clinical trials, data analysis, and data management. Dr. Peter
Thall, PhD, who has collaborated with Drs. Shpall, Rezvani, Bollard, and Molldrem for many
years on several different protocols and grants, will serve as Director of the Biostatistics Core.
The Core personnel, Dr. Thall and Roland Bassett, MS, are highly experienced biostatisticians
in the Department of Biostatistics of the MDACC. Dr. Thall, will coordinate the biostatistical
support. Conduct of clinical trials will utilize the Biostatistics Department's Clinical Trial Conduct
website. The specific aims of Core B are to (1) coordinate and manage biostatistical activities
and ensure that investigators have ready access to biostatistical consultation, including
experimental design, statistical modeling, data analysis, scientific interpretation, and reporting,
(2) provide statistical design, modeling, and data analysis for pre-clinical studies, (3) provide
statistical design and infrastructure for conduct of clinical trials, including sequentially adaptive
futility/safety monitoring and dose-finding, and (4) provide support for data management in
collaboration with the Administrative Core. If needed, the Core will draw on other resources and
personnel in the Biostatistics Department at MDACC.

Public health relevance
PROJECT NARRATIVE-CORE B Implementation of established statistical methods for study design and data analysis, or development of novel methods as needed, are essential to ensure the scientific validity of the research projects.